Pediatric Oncology Clinical Research Training Program

DESCRIPTION (provided by applicant): This proposal constitutes the renewal application of the Pediatric Oncology Clinical Research Training Program (POCRTP), developed by Baylor College of Medicine's Texas Children's Cancer Center. This training program is predicated on the premise that the development of pediatric oncologists and pediatric oncology nurses who are highly trained in clinical research is essential for continued progress to be made in the treatment of childhood cancer. This renewal application highlights the impressive academic accomplishments and progress of the individual Scholars recruited during the last ten years. The program is structured to provide a formal, comprehensive, multidisciplinary clinical research educational program that trains (1) pediatricians who have completed a three-year pediatric hematology-oncology fellowship training program and are board eligible or certified in that subspecialty and, (2) Ph.D. nurses with a career interest in pediatric oncology clinical research. Trainees, in this one-track program, are designated Paul Calabresi Scholars. They receive a two to three year comprehensive, didactic mentored training experience in the design, implementation, conduct and analysis of clinical research trials. The program emphasizes training in therapeutic research that occurs in team research settings in which basic and clinical scientists interact to expedite the translation of basic research discoveries into patient-oriented therapeutic cancer research. The program includes participation in a core didactic course in clinical investigation and trial design, provided through Baylor College of Medicine's Clinical Scientist Training Program, and an in-depth clinical research training experience focused in one of five specialized research areas, designated Pathways, chosen by the trainee. The POCRTP Pathways include Clinical Pharmacology, Neuro-oncology, Cell and Gene Therapy, Hematologic Malignancy or Solid Tumors. The research experience within each Pathway is tailored to meet the individual Scholar's long-term research goals. All Scholars receive comprehensive mentorship by both a laboratory research and a clinical research mentor and receive in depth instruction in clinical trial design, statistical analysis, research ethics and regulatory requirements and guidelines. In addition, Scholars design and conduct clinical trials in their respective Pathways. An elective rotation at the National Cancer Institute's Cancer Therapy Evaluation Program is a feature of this program. The experience to date indicates that Scholars who complete this program are exceptionally well trained in clinical research, very successful in obtaining NIH funding and well positioned to become future leaders in pediatric oncology clinical research.

Public health relevance
NARRATIVE This Pediatric Oncology Clinical Research Training Program provides a comprehensive clinical research educational program that trains pediatric oncologists and doctoral-trained pediatric oncology nurses in pediatric oncology clinical research. The program goal is to produce the next generation of leaders in the field of pediatric cancer research. The trainees, designated "Paul Calabresi Scholars", receive a mentored training experience in the design, implementation, conduct and analysis of clinical research trials with the ultimate goal of translating basic research discoveries into innovative treatments that will improve the prognosis of children with cancer.